ROS scavenging nanoparticles for mitigating oxidative stress in osteoarthritis

PROJECT SUMMARY
Oxidative stress plays a key role in the pathogenesis of osteoarthritis (OA) and is an important therapeutic target.
While antioxidants or agents that target the reactive oxygen species (ROS) have been investigated for treating
OA, many have demonstrated common disadvantages such as poor bioavailability and stability, as well as rapid
joint clearance or release profiles from delivery vehicles following intra-articular injections. Therefore, there exists
a critical need to localize and retain therapeutic levels of antioxidants within joint tissues for protection against
the deleterious effects of oxidative stress. This proposal explores the application of manganese dioxide
nanoparticles (MnO2 NPs) with antioxidant enzyme-like activity to reduce oxidative stress in OA joints while
addressing limitations of small molecule antioxidants and natural enzymes, such as cost and stability. In addition,
the properties of these nanomaterials can be tailored for tissue retention and cell targeting, which is important
for addressing critical barriers to therapeutic localization and uptake in joint tissues. Recently, we reported
engineering MnO2 NPs for uptake into cartilage and prolonged joint retention in vivo, as well as reduction of
inflammation-induced oxidative stress in cartilage in vitro. Given its limited capacity to regenerate, cartilage is
particularly vulnerable to oxidative stress and represents a crucial yet challenging tissue target. As such, this
proposal focuses on interrogating the mechanisms of MnO2 NP-mediated chondroprotection while testing the
efficacy of MnO2 NPs in an in vivo disease model. The central hypothesis is that MnO2 NPs will alleviate oxidative
stress after joint injury and prevent or delay the onset of OA. In Aim 1, we will examine how uptake mechanisms
and intracellular localization of MnO2 NPs affect compartment-specific ROS scavenging and the ability to rescue
specific antioxidant pathways in chondrocytes. Furthermore, the effects of intracellular targeting versus
extracellular retention on redox signaling, chondroprotective, and anti-inflammatory effects will be determined.
In Aim 2, we will evaluate the effects of MnO2 NP treatment on oxidative stress and OA progression in vivo in a
rat model of post-traumatic OA (PTOA). We will comprehensively evaluate the efficacy of the particles in
modulating ROS in vivo, mitigating OA-related histological and biochemical (synovial fluid) changes, and
alleviating OA-related pain and disability via behavioral assays. The proposed work will advance a new ROS
scavenging strategy for the treatment of PTOA that overcomes persistent challenges with the delivery of
antioxidants. The proposed work will also reveal key mechanisms involved in intracellular delivery to
chondrocytes and how location and timing of antioxidant delivery impacts disease mechanisms. The mechanistic
and comprehensive approach we propose here to characterize the effects of ROS scavenging by MnO2 NPs
may facilitate successful translation long-term of this and/or other antioxidant strategies for joint injuries and
disease.

Public health relevance
NARRATIVE Osteoarthritis (OA) is a highly prevalent degenerative joint disease for which there is no cure or effective therapy. Oxidative stress plays a key role in the development and progression of OA, however conventional antioxidants have had limited therapeutic success due to poor stability and bioavailability. This research aims to overcome these limitations to OA therapy, by engineering a nanomaterial with antioxidant properties that effectively reduces oxidative stress in cartilage and reduces inflammation to improve joint structure and function.